Towards a functional understanding of genotypic and phenotypic diversity across the Salmonella species

Project Summary
Despite the discovery of antibiotics nearly a century ago, infectious diarrheal diseases remain a global health
threat. One of the most prevalent diarrheal pathogens is Salmonella enterica, which infects over 100 million
people annually. This pathogen exhibits remarkable genetic diversity, with over 500,000 sequenced isolates on
NCBI displaying dramatic differences in host-range and disease manifestations. For example, non-typhoidal
Salmonella serovars (e.g Typhimurium, Enteriditis) cause self-limiting gastroenteritis in many hosts. In contrast,
human-restricted typhoidal serovars (e.g. Typhi, Paratyphi A) trigger enteric fever, a deadly systemic disease
with a mortality rate of up to 30%. While bioinformatic studies have computationally identify genetic differences
encoded across various Salmonella serovars, a comprehensive, functional approach towards characterizing the
genetic landscape in this pathogen has remained largely lacking. To address this gap, during my time in the
Monack group I have optimized random barcoded transposon sequencing (Rb-Tn-seq) in genetically diverse
Salmonella isolates, enabling me to rapidly identify fitness effects under dozens of host-associated stressors.
In this proposal, I will use my established Salmonella Rb-Tn-seq pipeline to systematically understand how
evolutionary pressures from both the human host and diverse bacteriophages contribute to the vast genetic
diversity in this pathogen. In Aim 1, I will expand upon my Rb-Tn-seq experiments by studying two
uncharacterized genes with serovar-specific fitness effects during host-associated stress: RS_03310, a putative
transcription factor associated with amino acid metabolism in Typhi and Paratyphi A, and BT_120, an unstudied
plasmid-encoded gene contributing to human macrophage infection in Typhimurium. In Aims 2 & 3, I will apply
this pipeline to a new direction- understanding how phage predation has contributed to Salmonella genome
evolution. To this end, I have received a panel of clinical Salmonella isolates and diverse phage isolated from
Malawi, Africa, where these Salmonella infections are endemic. In Aim 2, I will study how isolate-specific surface
features affect phage-bacterial interactions in the context of host-associated stress. In Aim 3, I will use
computational tools (MGEfinder) and functional genomic experiments to identify mobile genetic elements (MGE)
protecting against phage-associated stress. Using undomesticated clinical strains will greatly expand our
phenotypic understanding of the Salmonella genome. Furthermore, the genes and pathways identified in this
study may serve as novel therapeutic targets for Salmonella-triggered illnesses. My mentoring team includes
Denise Monack, a leading expert in the Salmonella field, as well as experts in phage (Dr. Jay Hinton, Dr. Alex
Gao) and MGE biology (Dr. Ami Bhatt). This training will prepare me for a career as an independent researcher
systematically studying genetic diversity and evolution across the Salmonella species.

Public health relevance
Project Narrative The genetic landscape of the enteric pathogen Salmonella is vast but remains underexplored. Using a panel of genetically diverse clinical Salmonella isolates from both generalist and human-restricted lineages, this study applies cutting-edge functional genomic approaches to systematically dissect how host-associated and phage- associated stress have shaped Salmonella genomic evolution at the isolate level. Ultimately, this work aims to identify novel therapeutic targets for the treatment of Salmonella-related diseases.